Long-read genome sequencing for the discovery of highly penetrant variation in rare diseases

Project Summary/Abstract
The goal of this proposal is to improve upon current methods to identify genetic contributors to rare diseases,
especially neurodevelopmental disorders (NDDs) in children. Finding such variants is both of fundamental
biological value and has potential clinical relevance to the affected individuals and their families. To improve
upon current approaches, a DNA sequencing platform from Pacific Biosciences, called “HiFi”, will be used.
Preliminary data suggest that HiFi can reveal disease-relevant genetic variants that were missed by standard
genome sequencing approaches. Genomes of 500 affected individuals will be sequenced using HiFi, and for
200 of them, their parents will also be sequenced (900 total genomes sequenced). This process will be optimized
to balance data quality, accuracy, and costs. Comprehensive maps of genetic variation and de novo genome
assemblies will be generated for each individual using a variety of methods, which will be systematically
benchmarked and improved. These results will be analyzed to identify variants in the proband that may be
causally related to their symptoms using commonly accepted standards for clinical interpretation of genomic
data. Variants found to be relevant for a particular proband’s symptoms will be validated with orthogonal testing
and returned to families by a genetic counselor, if such return is deemed appropriate by the referring clinician.
This study will address a major challenge in human genetics, and potentially lead to a fundamental change in
the way human genome sequencing is performed in both research and clinical settings.

Public health relevance
Project Narrative Genome sequencing technologies have greatly improved our ability to detect the genetic causes of rare diseases, such as neurodevelopmental disorders (NDDs), but disease-relevant genetic variants still cannot be found in most individuals with a rare disease. New sequencing technologies hold great potential to uncover genetic variation missed by current approaches, and this proposal tests one such approach, called “HiFi”, from Pacific Biosciences. 500 probands, and 400 of their parents, with an unexplained rare disease will be sequenced using HiFi to identify disease-associated, clinically relevant variants and to substantially improve upon sequencing technologies in research and clinical settings.